SYSTEMATIC UNDERSTANDING AND ELIMINATION OF MISINFORMATION ONLINE

To develop digital tools to identify and combat malicious digital bots that spread misinformation about infectious disease treatments and vaccines, including COVID-19 vaccines.